Mitigation of Radiation Induced Gastrointestinal Syndrome.

Abstract:
Currently RAS has been considered a high value target in cancer drug development considering
that over 30 percent of all human cancers – including 95% of pancreatic cancers and 45% of
colorectal cancers — are driven by mutations of the RAS family of genes. The first clinical
launch of a G12C KRAS inhibitor is Lumakras™ (sotorasib) from Amgen for non-small cell lung
carcinoma and Mirati Adagrasib™ is on the way to approval with its G12C inhibitor however, the
development of G12D and V inhibitors of KRAS are stalled in the preclinical realm with similar
strategies used for G12C inhibitors which is likely more difficult or impossible to apply to other
mutations. In addition, then there is also the challenge of overactive wildtype RAS mutations
where targeting mutations in the protein become difficult with an overactive RAS pathway which
can result from RAS upregulation or dysregulation of its partnering proteins. This is not
addressed by the current approaches which seeks to inhibit the mutant forms only but in fact
has led to a mechanism of resistance within the mutant forms of RAS with a complex network of
pathways where isotypes of RAS are involved. Here we present what is unfolding as another
possible target for oncogenic RAS. A hallmark of all oncogenic RAS is suppression of
Phosphatase and tensin homolog is a phosphatase (PTEN) expression. PTEN is a multi-
functional tumor suppressor that is very commonly lost in human cancer but is a requirement in
cancerous RAS signaling to prevent the cells from being able to die (causing immortalization).
Thus, this is widely regarded as a driver mutation. The other hallmark of oncogenic RAS
signaling is a protein known as GSK3 is overexpressed. We have recently reported BCN057
restores PTEN expression to abrogate the immortalized phenotype in oncogenic KRAS. Why
this is important is because the signal transduction “wiring” appears to differ in KRAS mutant vs
normal tissue. Thus, normal tissue responds by increasing its resistance to chemotherapy and
radiation while inducing cell death in the KRAS mutant tumor cells resulting in an increase in the
therapeutic index. This is a breakthrough for oncogenic KRAS epithelial cancers and colorectal
cancer treatment and may eventually have significant implications for a variety of cancers. In
the US alone there are over 150,000 new cases of colorectal cancers and studies like
Foundation Medicine (FM) estimate a KRAS mutation frequency of approximately 50%. In
summary, the proposed work will provide a clear path to subsequent studies related to product
development in a phase II application.

Public health relevance
PUBLIC HEALTH RELEVANCE: Excluding skin cancers, colorectal cancer is the third most common cancer diagnosed in the United States. The American Cancer Society's estimates for the number of colorectal cancer cases in the United States for 2022 are: 106,180 new cases of colon cancer. 44,850 new cases of rectal cancer. According to Foundation Medicine (FM) it is estimate that KRAS mutation frequencies of approximately 50% exist in colorectal cancers. KRAS mutations are present in approximately 25% of all tumors, making them one of the most common gene mutations linked to cancer. They are frequent drivers in lung, colorectal and pancreatic cancers. KRAS drives 32% of lung cancers, 40% of colorectal cancers, and 85% to 90% of pancreatic cancer cases. Mutations G12C, G12D/V and G12/13R are some of the most common KRAS mutations but G12D and V dominate colorectal and pancreatic cancers which is the largest and what we are targeting in this proposal. This work involves breakthrough technology which can target hard to treat KRAS mutations such as G12D and G12V where there are no currently approved drugs to treat this deadly disease. It is estimated that for colorectal cancers alone, this research and finding may impact 30-40% of the colorectal cancer population equating up to ~ 60,000 people annually in the USA alone.